COOPERATIVE TISSUE BANK OF HIV POSITIVE MALIGNANCIES

{\rtf1\ansi\ansicpg1252\deff0\deflang1033{\fonttbl{\f0\fswiss\fcharset0 Arial;}} {\*\generator Msftedit 5.41.15.1515;}\viewkind4\uc1\pard\f0\fs21 The AIDS and Cancer Specimen Resource (ACSR) of the National Cancer Institutes (NCI) AIDS Malignancy\par Program, provides HIV/AIDS-related malignant tissues and data to funded/approved cancer researchers to\par promote a global understanding of the relationships between HIV infection and certain cancers. The Mid\par Region ACSR (MR-ACSR) consortium, including: The Ohio State University (OSU), Emory University, Rush\par University, University of Tennessee, Memphis, and East African affiliates in Uganda and Kenya, proposes to\par (specific aim 1) maintain a mid-region ACSR (MR-ACSR) biorepository with affiliates that is compliant with all\par ACSR rules and recommendations including the NCI Best Practices for Biospecimen Resources and\par applicable federal regulations and is adequately structured with an Operations Office to perform the\par principal tasks of collecting, enhancing, storing, and distributing HIV-related, quality assured human\par tumor tissue with associated clinical, pathological, visual and demographic data to approved\par investigators. To assure best use of these resources the MR-ACSR proposes to (specific aim 2) collaborate\par with ACSR regional biorepositories, NCI AIDS Malignancy Program (AMP) and other NCI AIDS related\par malignancy and cancer biorepository programs and The Ohio State University Department of Pathology's\par Human Tissue Resource Network (HTRN) to leverage quality specimen and data availability for translational\par research in area of HIV/AIDS-related malignancies. To accomplish the overall objectives of the NCI to\par promote good health, the MR-ACSR must (specific aim 3) develop original and innovative programs to\par improve the quality, availability and relevance of biospecimens and associated data using the laboratory\par facilities and specimen resources of the MR-ACSR consortium including the East African affiliates, The Ohio\par State University Department of Pathology's HTRN and the Department of Biomedical Informatics caBIG\par project. MR-ACSR proposes the deployment of a new tissue fixation method to improve preservation of\par RNA, DNA and tissue proteins for research tissues. Tissue microarray (TMA) construction can be deployed\par using a "field" construction format that facilitates diagnostic specimen collection in resource constrained\par locations. We propose to facilitate the tissue phenotyping of lymphoma (NHL) in sub-Saharan Africa using\par this TMA format with follow up distant processing and immunohistochemical staining. The MR-ACSR also\par has a supporting digital microscopy facility for remote visual Internet consultation using digitized images of\par tissue for data sharing with our collaborators in East Africa, particularly related to diagnostic consultation and\par review of pathology tissues in cancer clinical treatment trials. Finally, to make the best use of visual data and\par distant collaboration, the MR ACSR proposes to work with the developers of caGrid as a clinical resource for\par digital image data.\fs20\par \par }